Specialized Training in Anesthesiology Team Science

Project Summay/Abstract
The main goal of the Specialized Training in Anesthesiology Team Science (STAT) Program is to develop
competent investigative anesthesiologists in broad areas of research including basic, clinical/translational, and
outcomes research. This novel training plan allows for the creation of an interdisciplinary team of mentors to
form innovative research projects using a collaborative team science approach. Our program structure ensures
that each STAT trainee will have a unique individualized training plan that will assist them into entry-level, full-
time, academic faculty positions in Anesthesiology. A mentorship team will be created for each STAT trainee
which includes both extramurally funded biomedical researchers and leaders with Anesthesiology to help guide
their career development. A total of 32 participating faculty mentors representing 17 departments are categorized
into the 3 main areas of research: basic science, clinical/translational, and outcomes. STAT trainees will be
exposed to interdisciplinary research and undergo formalized training in grant/manuscript writing, biostatistics,
rigor, and responsibility in research, and cover ethical topics in research. The STAT track allows for a research-
intensive experience during their clinical training which includes research elective time followed by 24 months of
NIH-supported research following the completion of their residency. Our goal is to recruit, develop, and retain
motivated individuals from a diverse background that will broaden the scope of research in Anesthesiology. The
proposed training plan aims to continue the strong tradition of developing physician-scientists within the
Department of Anesthesiology at MCW while branching out into various disciplines to perform cutting-edge
research. Individuals who complete the STAT program will be well positioned to succeed in the academic
environment, make impactful discoveries, and become future leaders in our field.

Public health relevance
Project Narrative The evolving needs of the specialty of Anesthesiology include: a strengthening of the scientific foundation to grow new fundamental insights and offer the highest quality of care to the expanding complex patient population requiring anesthesia perioperative care. The purpose of the STAT Training Program is to develop a subset of outstanding investigators trained to conduct precise and impactful research of relevance to anesthesiology and perioperative medicine. This new application will build upon our past success with developing physician scientists from diverse backgrounds, will reveal a strong pipeline of candidates, and will describe expert faculty mentors that will broaden our approach to innovation with Anesthesiology.